Cytoxic and Genotoxic Effects of Manufactured Nanoparticles on Stem Cells

Project Summary The use of NPs in commercially available products is rapidly increasing. As their use becomes more widespread, human exposure will consequently increase. Due to NPs unique properties, the potential hazards of NPs are only now being identified. There is a growing need for systematic toxicity studies especially to the very special cell type-stem cells. However, information is very limited regarding how stem cells respond to NPs. Our previous studies indicated the carbon nanotube and nanosilver particles can induce a DNA damage response in mouse embryonic stem cells. Stem cells are a unique cell population with the ability to undergo both self-renewal and differentiation. Adult stem cells constantly provide new cell lineages in our body. Increasing amounts of evidence suggest that stem cells may be the sources of mutant cells that give rise to cancerous tumors and maintain tumor growth. The systemic and detailed characterization of both cytotoxic and genotoxic Microsoft Office Word 2007.lnk effects of manufactured NP exposure to both embryonic stem cells, induced stem cells (iPS) and adult stem cells will thoroughly evaluate the health and safety effects of NPs and greatly enhance consumer confidence. In this proposal, we will be initially using four NP types that are, or will be, prominently used in commercially available products: carbon NPs (car wax, fuel lines, cosmetics), silver NPs (antimicrobial wound dressings, odor-reducing socks), titanium dioxide NPs (sunscreens, paints), and zinc oxide NPs (sunscreens). It is vital to have confidence in the suppliers of these NPs. We are fortunate to have strong collaborative links with NP manufacturing experts within the University of Dayton and other institutes who will provide these particles. We propose the following specific aims: Aim 1. Characterize the impact of these selected manufactured nanoparticles to stem cells self renewal and differentiation potentials. Mouse embryonic stem cells, induced human pluripotent stem cells (ihPS), and human mesenchymal stem cells will be used for this study. Aim2. Investigate p53 activation as a possible molecular marker to study the stem cell cytotoxic and genotoxic response to these selected manufactured nanoparticles. Aim3. Using an endogenous molecular marker adenine phosphoribosyltransferase (Aprt) as a reporter to study genotoxic effect to these selected nanoparticles.

Public health relevance
PROJECT NARRATIVE The nanotechnology revolution has the potential to top the industrial revolution and turn over $1 trillion. There is a need to establish an assay to determine the toxicity of manufactured NPs and their impact on human health and the environment especially to the very special cell type-stem cells. Stem cells have the ability to divide indefinitely, and can give rise to many different cell lineages. The functions and properties of ES cells are very different from that of somatic cells. Mutation in ES cells can give ride to cancer and potentially compromise multiple cells lineages and affect the well being of subsequent generations. The objective of this project is to develop a rapid and cost effective protocol for determination of the toxicity of manufactured nanoparticles to both embryonic stem cells and adult stem cells. Four types of nanoparticles (carbon, silver, titanium dioxide, and zinc oxide) will be manufactured and assessed the toxicity to stem cells. This proposal will provide a comprehensive database of toxicity of manufactured NPs to stem cells and greatly enhance consumer confidence.